Contribution of innate immune cells in promoting antibiotic tolerance

PROJECT SUMMARY
Despite high levels of antibiotic exposure, some individual bacterial cells survive multiple courses of
antibiotic treatment due to antibiotic tolerance, which is a transient phenotypic change associated with reduced
metabolism or slowed growth. It remains unclear what drives the formation of tolerant cells within host tissues,
and whether the antimicrobials generated by the host immune system may contribute to the formation of
antibiotic tolerant bacterial cells. To investigate the impact of host-derived stresses, specifically reactive
oxygen species (ROS) and reactive nitrogen species (RNS), on antibiotic tolerance, we are probing the growth
of the human pathogen, Yersinia pseudotuberculosis, in a mouse model. Within host tissues, this microbe
replicates to form clonal clusters of extracellular bacteria that directly interface with a layer of neutrophils that
are, in turn, enveloped by a layer of macrophages. The bacterial subpopulation at the outer edge of the
microcolony responds to neutrophil contact by upregulating expression of the anti-phagocytic, type III secretion
system (T3SS). These host cell-associated bacteria are part of a larger peripheral layer, which responds to
and detoxifies diffusible nitric oxide (NO) originating from distal macrophages. This system clearly allows us to
distinguish the spatial location of individual bacterial cells, and to determine if host cell interactions, or
interactions with the antimicrobials they produce, are contributing to the formation of antibiotic tolerant bacterial
populations.
We hypothesize that antibiotic tolerant bacteria emerge within host tissues due to innate
immune cell-derived ROS and RNS. We have recently developed a novel reporter system to detect antibiotic
(doxycycline) exposure within individual bacterial cells in host tissues, and will use this tool to: 1) define the
roles of immune cell-derived ROS and RNS in promoting of antibiotic tolerance, 2) determine the pathways
utilized by doxycycline-tolerant subpopulations within host tissues. In addition, we have also developed an
innovative agarose droplet-based system to model growth within host tissues, which will enable kinetic
analyses, and provide a more thorough understanding of how bacterial communities interact with immune cells
in vivo. The extent of bacterial heterogeneity within host tissues has been largely unexplored, making this a
novel, understudied aspect of the disease process, and the focus of research in my lab. Identifying and
understanding the cues that promote the formation of tolerant bacterial subpopulations has important
implications for the design of novel therapeutics, which need to target all subpopulations to effectively eliminate
bacteria within host tissues.

Public health relevance
PROJECT NARRATIVE Antibiotic tolerance occurs when subpopulations of bacteria have reduced susceptibility to antibiotics, typically due to altered metabolic activity, which can result in antibiotic treatment failure in patients. It remains unclear what role host innate immune cells may play in this process, and whether antimicrobial stresses, such as reactive oxygen species (ROS) and reactive nitrogen species (RNS), are sufficient to promote antibiotic tolerance within host tissues. This proposal will address this critical knowledge gap, and allow us to better understand the potentially deleterious role innate immune cells may play in stressing, but not sufficiently killing, bacterial populations.